Molecular Atlas of Lung Development Program (LungMAP) Phase 3 - Data Coordinating Center

PROJECT SUMMARY
Diseases of the lung are a significant global health burden. To develop the next generation of therapies for
diverse lung diseases, system models informed by an ever-increasing repertoire of molecular omics, cellular,
spatial imaging, and pathological datasets are desperately needed. The LungMAP DCC is responsible for data
collation, re-analysis, and integration; secondary annotation tracking; developing tools to facilitate collection,
sharing and data dissemination; operating a web resource for data, expertise, and collaboration; and
coordinating activities across the Research Centers (RCs) and Human Tissue Core. The DCC also must facilitate
literacy for investigator use of developed tools and best practices for analysis, data provenance and metadata
annotation, and engage the larger research community. To cultivate future discoveries by the lung community,
we have begun aggregating a diverse collection of single-cell atlases for multiple species and diseases into
highly curated lung cell atlases as queryable datasets, with an emphasis on dynamic visualization, figure
generation, re-analysis, cell-type curation, and automated annotation. In LungMAP Phase 3, to support the
discovery of novel cellular and gene regulatory mechanisms, the LungMAP DCC will assemble, annotate,
analyze and distribute multi-omic catalogs of diverse lung diseases, expand and enrich our portal ecosystem
and lead community curation efforts. These resources will be deployed for broad reuse throughout the lung
research community. Our specific aims are to: 1) Advance lung research, education, cooperation, and scientific
dissemination efforts across the lung research community. The LungMAP Administrative Coordination Center
(ACC) will coordinate scientific and operational administrative activities to maximize synergies and research
opportunities within the consortium and with community partners. 2) Create a multi-omic catalog of lung diseases
leveraging LungMAP contributed and community data sources. The DCC will collect, organize and analyze a
large collection of LungMAP and community datasets to produce harmonized disease cell atlases and disease
focused portals. 3) Develop LungMAP.net into an extendable knowledge base of lung disease network biology.
The LungMAP.net ecosystem will expand to serve as a hub for research as a living resource and knowledge
base for normal and disease lung modeling through integration of agile AI-driven tools. Thus, the LungMAP
DCC will deliver a comprehensive corpus of standardized and integrated lung data and knowledge, to nominate
new targets for therapy, new regulators and disease subtypes.
1

Public health relevance
PROJECT NARRATIVE Diseases of the lung are among the leading causes of death in the United States and worldwide. In Phase 3 of the Molecular Atlas of Lung Development Program (LungMAP), the data coordination center (DCC) in conjunction with its research centers and human tissue core, will work to define the regulatory mechanisms of lung disease progression and nominate new targets for therapy. To achieve this goal, the DCC will develop advanced systems biology resources and tools leveraging advances in artificial intelligence, harmonize LungMAP datasets and will coordinate educational outreach. 2